NON-HUMAN PRIMATE MODELS OF ALCOHOL CONSUMPTION AND AGGRESSION

During the past year, research has been pursued concerning (1) Etiological mechanisms underlying individual differences in alcohol consumption in rhesus monkeys, with an emphasis on paternal genetic contributions; (2) The relationship between social competence and serotonin in ferally living monkeys: To assess the generalizability of our laboratory findings, and to obtain a subject pool of inappropriately aggressive individuals with sufficient numbers to perform parametric analyses, we continued to investigate ferally-living adolescent male monkeys drawn from a subject pool of 4500 rhesus monkeys living on an island off the coast of South Carolina; (3) Developmental patterns of rhesus monkeys selectively bred for extremes in CSF 5-HIAA: A major part of the past year has involved the development of a selective breeding program to breed for extremes in CSF 5-HIAA concentration. Both the parents and the infants have been carefully assessed to investigate parental genetic contributions to excessive aggression and alcohol consumption; (4) Genetic differences in the serotonin system using molecular genetics techniques, including amplification of the serotonin 1A receptor gene in monkeys with increased and diminished CSF 5-HIAA, development of fibroblast cell lines to acquire DNA, and the development of techniques to type tryptophan hydroxylase; (5) Assessment of the pharmacokinetics of imipramine in monkeys showing excessive anxiety under both baseline and stressful conditions.